2025 Neuroethology: Behavior, Evolution and Neurobiology Gordon Research Conference and Gordon Research Seminar

Project Summary
This proposal requests funds to support the 11th Gordon Research Conference (GRC) in Neuroethology, to be
held June 29-July 4, 2025, at Renaissance Tuscany Il Ciocco in Lucca, Italy. Our objectives are 1) to organize
a meeting that presents exciting, unpublished research illustrating different perspectives on how to study
neural control of behavior to catalyze new interdisciplinary collaborations, and 2) to grow the field by
welcoming early career scientists as respected members of the community with opportunities to share their
work, receive feedback, and build connections. We will accomplish these goals by crafting a program of talks
around themes for informative comparisons and by taking full advantage of the GRC structure of poster
sessions, shared meals, and social activities as venues to encourage deep discussions.
Neuroethology takes a broad view of ways to understand how nervous systems control behavior, a basic
science question with medical and societal implications well aligned to the NINDS mission. This conference
brings together researchers at different career stages, with different backgrounds, working in different animals,
with different techniques, for a small interactive conference that exposes attendees to research they might not
have come across at other meetings or in their usual science literature reading. While we are all fascinated by
neural control of animal behavior in their environment, we have a lot to learn from each other.
The 2025 GRC Neuroethology scientific program will blend powerful historical intellectual traditions with
modern experimental approaches to make progress toward our shared goals of understanding how nervous
systems produce behaviors and growing a vibrant, diverse scientific community. Session topics include
measuring behavior in the lab and in the field, specialized sensors, adaptations for life at environmental
extremes, invertebrate cognition, and how behaviors evolve with examples from different levels of analysis.
The GRC will be preceded by a two-day Gordon Research Seminar (GRS) organized by a graduate student
and postdoctoral fellow along with invited mentors that are leaders in the field. The GRS offers graduate
students and postdocs an opportunity to present their current research and to build a sense of community prior
to attending the GRC. New ideas, collaborations, and research directions grow when there is time for trainees
to interact deeply with established experts. The structure and culture of the GRS/GRC meetings promote
these critical interdisciplinary interactions. Funds received from the NIH will enable participation by more
scientists by defraying registration and travel costs incurred by students, postdocs, and invited speakers, with
preference being given to early career scientists, women, and members of under-represented groups in STEM.

Public health relevance
Project Narrative The theme of the 2025 Neuroethology Gordon Research Conference is to develop comparative interdisciplinary approaches, grounded in quantitative measurements of natural animal behavior, to uncover shared design principles of neural control. Research presentations will feature many animal systems and levels of analysis from genes and molecules through neurons and circuits to organisms and communities. Conference participants will include students, postdocs, early-career faculty, and experienced mentors to establish collaborations that will reveal general principles of neural coding that impact treatments for human locomotion, navigation, sensing, and brain and spinal cord dysfunctions.